Generative Modeling of Excitation:Inhibition Balance Abnormalities in Schizophrenia

PROJECT SUMMARY / ABSTRACT:
Cognitive deficits are, arguably, the most prevalent, the most disabling, and the most economically costly
symptom of schizophrenia (SZ). There are, however, no FDA-approved medications to improve cognitive
function in SZ. Computational models have proposed that cognitive deficits in SZ arise from disruptions to
cortical excitation:inhibition (E:I) balance, and these models have inspired new outcome measures for
randomized control trials (RCTs), as well as new model paradigms for SZ. Nevertheless, it is unclear whether
computational models of E:I balance in SZ will spur innovations in cognitive-enhancing therapeutics.
Conventional approaches to modeling of E:I balance in SZ are limited in several ways, which may negatively
impact their ability to improve the assessment and treatment of cognitive deficits among those with SZ. The
following F31 NRSA proposal seeks to translate a recently-validated modeling approach, which does not
exhibit these limitations, to the study of E:I balance in SZ. Mesoscale Individualized Neurodynamic (MINDy)
modeling, which was created by members of this NRSA proposal team, is an approach for inferring the
biophysical parameters of an individual’s brain using functional magnetic resonance imaging (fMRI) data.
MINDy models provide a proxy-measure for E:I balance that is, unlike conventional computational models of
E:I balance in SZ, both statistically reliable (Test-Retest R > 0.7) and quick to compute for every region of
interest in the brain (~1min compute time). The following NRSA proposal leverages these advantages to
investigate disruptions in brain-wide E:I associated dynamics among those with SZ using a wide range of
clinically-relevant study designs. For aim one of this NRSA, we will use MINDy to investigate brain wide
disruptions to E:I-associated dynamics among individuals with SZ by using resting-state fMRI data from the
Human Connectome Project – Early Psychosis (HCP-EP) study. While conventional approaches have
demonstrated that SZ is primarily associated with disruptions to E:I balance in association cortical areas such
as the prefrontal cortex, there is some evidence that E:I balance may also be disrupted in sensory cortical
areas. This has not been explored with computational models of E:I balance. We hypothesize that MINDy will
uncover disruptions to E:I-associated dynamics in both association and sensory cortical areas among those
with SZ. For aim two of this NRSA, we will use MINDy to investigate genetic contributions to individual
differences in brain-wide E:I balance among a sample of approximately 900 monozygotic and dizygotic twin
pairs from the Adolescent Brain and Cognitive Development Twin (ABCD-Twin) study. While existing work
suggests that general changes in gene expression across the neocortex are related to differences in E:I
balance between cortical areas, aim two of this NRSA proposal will be the first study to investigate whether the
distribution of E:I balance across the brain is related to individual differences in heritable genetic factors. Lastly,
aim 3 of this NRSA proposal will combine MINDy with a computational model of decision-making, called the
drift-diffusion model, in order to investigate links between brain-wide E:I balance and the efficiency of evidence
accumulation during perceptual decision making. The contribution of E:I disruptions to cognitive deficits have
primarily only focused on the association cortex and also have only focused on working memory paradigms. In
order to address both of these gaps, this F31 NRSA proposal will use MINDy modeling to investigate
relationships between brain-wide E:I disruptions in SZ and perceptual decision making.

Public health relevance
Computational models suggest cognitive deficits in schizophrenia (SZ) may arise from the effects of cortical excitation:inhibition (E:I) balance disruptions in regions of the association cortex. These models have computational and statistical properties that make them difficult to translate to clinically relevant contexts. The proposed project uses a novel computational approach, Mesoscale Individualized Neurodynamic (MINDy) modeling, to translate computational models of E:I balance to large-scale neuroimaging datasets, genetically- informative research designs, and novel asessments of cognitive function in schizophrenia.